R-loop-induced DNA damage during immunoglobulin class switch recombination

Project Summary/Abstract Class switch recombination (CSR) is a genetic process where a B cell switches antibody isotype production through site-­specific intra-­chromosomal DNA rearrangement stimulated by the formation of DNA double-­strand breaks (DSBs) at the immunoglobulin heavy chain (IgH) locus. DSBs are normally repaired by the non-­homologous end-­joining (NHEJ) and alternative-­end joining (alt-­EJ) DNA repair pathways. During CSR, DSB formation is highly regulated involving a complex interplay of transcriptional activation, protein recruitment and chromatin reorganization. Understanding the factors regulating DSB formation and repair has a high impact on lymphomagenesis. R loops are three stranded RNA:DNA hybrid structures formed at IgH during CSR. While R loops are implicated in promoting DSB formation at IgH, their role in class switch recombination remains undefined. We find that mice defective for R loop removal are proficient at class switch recombination, however B cells contain unrepaired breaks and chromosome fusions at IgH. Recurrent oncogenic translocations involving IgH distinguish many human lymphoid malignancies. These translocations originate from mis-­repaired DNA double stand breaks (DSBs) generated during normal lymphocyte development. Our goal is to determine how persistent R loops impede DNA repair during CSR, and the role R loop metabolism plays in suppressing genome instability at IgH. We hypothesize that persistent R loops block efficient DNA repair by non-­homologous end joining at the immunoglobulin heavy chain locus during class switch recombination, leading to persistent, unrepaired breaks. To test this hypothesis, two mouse models will be employed: the SETX mutant lacks the Senataxin (SETX) helicase that unwinds R loops;? and Rnaseh2b is defective for the RNase H2 nuclease that specifically digests the RNA component of R loops (RNH2B). We will functionally dissect the consequences of aberrant R loop formation on DNA repair and chromosome fusions arising during CSR in SETX-­/-­, RNH2Bf/f, and SETX-­/-­ RNH2Bf/f cells (Aim 1). To define the impact persistent R loops have on NHEJ, we will characterize DNA repair protein recruitment in SETX-­/-­, RNH2Bf/f, and SETX-­/-­ RNH2Bf/f cells (Aim 2). We will also identify genomic loci involved in IgH translocations using high-­throughput genome-­wide translocation sequencing (HTGTS-­Seq), in collaboration with Dr. Feyredoun Hormozdiari. Finally, we will define the molecular pathways driving the frequent chromosome fusions observed in SETX-­/-­ RNH2Bf/f cells (Aim 3). Our work will define how persistent R loops interfere with class switch recombination, leading to unrepaired breaks, and will uncover the molecular mechanisms promoting chromosome fusions at IgH. Enzymes regulating R loop metabolism will also provide an attractive target for developing novel cancer treatment.

Public health relevance
Public health relevance Defective repair of DNA damage causes the accumulation of mutations and genomic rearrangements that predispose to cancer development. Setx and RNase H2 protect against immunoglobulin (Ig) translocations driving many lymphoid cancers. Understanding the impact of defects in Senataxin and RNase H2 on the formation of genomic mutations and rearrangements will provide novel and important insights into the molecular events driving tumorigenesis.